PAI-1, tPA, TFPI and Endometrial Endothelial Cells in Uterine Hemostasis

PROJECT SUMMARY/ABSTRACT
Up to 30% of menstruating individuals experience heavy menstrual bleeding (HMB) at some point. HMB is
associated with complications such as iron deficiency anemia and increased requirements for medical and
surgical interventions, as well as decreased quality of life and missed work or school. While HMB is associated
with structural anomalies such as fibroids, bleeding disorders and anticoagulation, in many cases there is no
known cause. Prior studies have demonstrated a positive association between increased tissue plasminogen
activator (tPA), an anticoagulant factor, and plasminogen activator inhibitor-1 (PAI-1), a procoagulant factor,
and HMB. Such factors, along with other important pro- and anticoagulant factors, such as von Willebrand
factor (VWF) and tissue factor pathway inhibitor (TFPI) are expressed by endothelial cells. We hypothesize
that endometrial endothelial cells (EECs) regulate uterine hemostasis through the up and down
regulation of coagulation factors and that differences in such factors contribute to HMB.
We propose to investigate the role of tPA, PAI-1, TFPI, VWF multimers and EECs in uterine hemostasis
through (1) quantification of tPA, PAI-1 and TFPI in the menstrual blood of women with and without HMB on
each day of menstrual bleeding, (2) comparative analysis of VW multimer distribution in the same samples and
(3) single cell RNA sequencing of endometrial biopsy samples, including EECs, with attention to coagulation
factors. The results of this study will be used to generate testable hypotheses regarding management options
for HMB.
Dr. Samuelson Bannow has generated data supporting the important contribution of coagulation factors to
differences in menstrual bleeding by demonstrating increased risk of HMB in women who use oral
anticoagulants associated with higher peaks of activated anti-factor X effect compared to those with lower peak
effect. Her primary mentor, Dr. Alison Edelman, has extensive experience with clinical and translational studies
of menstrual bleeding and her co-mentor, Dr. Les Myatt, has expertise in women's health and basic science
techniques such as cell culture and RNA sequencing. Her advisors will provide additional expertise and
guidance in interpretation of RNAseq data and biostatistics. The proposed training will enable Dr. Samuelson
Bannow to acquire clinical and research expertise in women's health, gain experience with translational and
basic scientific research methods, and develop skills in granstmanship and scientific communication.
Importantly it will also allow her to develop the necessary research infrastructure and program for future,
independently funded studies in the pathophysiology and management of excessive uterine bleeding.

Public health relevance
PROJECT NARRATIVE Heavy menstrual bleeding (HMB) is a common and problematic occurrence in menstruating individuals and pro- and anti-coagulant factors, such as tissue plasminogen activator, plasminogen activator inhibitor-1, tissue factor pathway inhibitor and von Willebrand factor, all expressed by endothelial cells, play important roles in regulating menstrual blood loss. Through measurement of these levels in the menstrual blood of women with and without HMB, this study will establish the role of these factors in menstrual blood loss. This study will further establish the role of endometrial endothelial cells (EECs) in regulating these and other factors by performing single cell sequencing of endometrial cells, including EECs and comparing gene expression from women with and without HMB.